Unraveling the molecular connections that link circadian rhythms and lipid metabolism

SUMMARY: This Administrative Supplement for Equipment requests supplemental funds to
purchase a multiplex fluorescent imaging system. The ability to simultaneously image and analyze
multiple fluorophores will greatly facilitate the proposed studies of lipid-protein-DNA interactions
and enable us to address more complex biological questions. This instrument is an all-in-one
imaging system to detect and analyze multiplex fluorescent labeling, chemiluminescence,
bioluminescence, and virtually all common types of stains in gels, blots, and plates. The capacity
of sensitive multiplexed imaging enhances research efficiency, data quantification, and
reliability.

Public health relevance
PROJECT NARRATIVE: An all-in-one imaging system with multiplex fluorescent detection and quantification will facilitate greatly the funded project to investigate and elucidate the interconnection between the molecular clock and lipid metabolism.